Orexin Signaling in the Mouse Cochlea

The research undertaken for this proposal is significant because it represents the first investigation of the role
of Orexin signaling in the cochlea and as such, will result in novel basic knowledge of a new signaling pathway
related to cochlear function. We will also define potential safety concerns regarding impacts to hearing health
associated with the use of an insomnia drug that is already used by a significant portion of the US population.
The Orexins are a family of two peptides that in the brain are exclusively expressed in hypothalamic neurons.
Both Orexin receptors, however, are widely dispersed throughout the brain. Defective Orexin signaling has
been linked to sporadic nonfamilial narcolepsy, the most common form of narcolepsy, and therefore most
research on Orexin signaling targets sleep/wake behavior. Using immunohistochemistry, we show that the
Orexin pre-prohormone, both mature Orexins peptides, and their receptors are expressed in the cochlea. We
demonstrate that Orexin A/B pre-prohormone gene null mice (thus lacking all Orexin ligands) do not recover
ABR thresholds following noise exposures that induce classic TTS in wild type mice. This is a translationally
significant finding because Ox1R and Ox2R are targets of Orexin receptor antagonist pharmaceuticals such as
Suvorexant (Belsomra®) marketed to treat insomnia. Approximately 30% of adults in the US report symptoms
of insomnia and 4% reported prescription sleep aid use in the month prior to a 2013 CDC poll. While sleep aids
are meant for brief duration use, they are often used for long periods of time (months to years). This is
especially true of aged individuals and those suffering from any of numerous other conditions (PTSD, anxiety,
etc.). A major question is whether a latent risk exists in using Orexin-targeting insomnia medications- do these
drugs leave patients at risk for hearing dysfunction, especially if taken consistently over time that would result
in incomplete clearance of the drug? This work is further translationally relevant because sleep aids are often
used by older individuals, who as a population suffer from abnormal sleep patterns/insomnia and also typically
are experiencing normal age-related hearing dysfunction. Our goal for this project is to: 1) verify and expand
our preliminary data obtained with Orexin ligand nulls by demonstrating which receptor (Ox1R , Ox2R, or both)
contribute to the loss of hearing following moderate-level sound exposures; and 2) begin an assessment of the
mechanisms underlying the observed dysfunction associated with loss of Orexin signaling. We will use a
combination of morphological (immunostaining for afferent synapses under IHCs), physiological (ABRs and
DPs), and protein expression (cytokine arrays) analyses to investigate the role of Orexin signaling in
maintenance of hearing sensitivity following noise exposures. We will also examine the noise-induced local
immune responses of the cochlea by assessing the inflammatory state and numbers of immune cells infiltrating
the cochlea following Orexin receptor genetic manipulation and noise exposure.

Public health relevance
We have discovered that: 1) Orexin peptides and receptors, typically considered to be involved with sleep-wake cycles and feeding behaviors, are also expressed in the cochlea, and 2) that ablation of the gene responsible for producing the Orexin peptides exacerbates noise-induced hearing loss. Approximately 30% of US adults report symptoms of insomnia, and while medications used to alleviate insomnia are meant to be used for a short time, many people continue taking insomnia medication for long periods. Because a relatively new insomnia medication silences the Orexin receptors, individuals using this drug long-term could be at previously unrecognized risk for cochlear dysfunction and general hearing loss.